Admin Core

The overall goal of our Midwest Roybal Center for Health Promotion and Translation is to advance the
science, translation, and practice of health promotion programs for older adults at risk of Alzheimer’s
Disease and Alzheimer’s Disease Related Dementias (AD/ADRD) in order to improve the functioning
(physical and cognitive) and quality of life of this growing segment of our population. To achieve this
mission, this renewal Center will sponsor, facilitate and monitor the development and testing of
interventions that will advance scientific knowledge in four areas of thematic focus. The areas of research
focus are: a) Develop and test principle driven interventions to increase physical activity (PA) among older
adults at risk of AD/ADRD; b) Design interventions to maintain and/or enhance cognitive function and
mobility; c) Harness technology to promote healthy cognitive aging and to improve the scalability of existing
interventions for cognitive health including PA, diet, and stress reduction; d) Target mechanisms of
behavior change to promote and sustain behavioral and lifestyle change.
We will work with an outstanding External Advisory Committee and talented UIC faculty on our Executive
Committee to foster and execute the following Aims: Aim 1. Develop and maintain a strategic vision; ensuring
that all relevant Stages of expertise in the NIH Stage Model will be represented within the Center and the ways
that experts across the Stage Model will interact; Aim 2. Manage an External Advisory Committee that will
include expertise in behavioral intervention development and will oversee Center functioning and assist the
Directors in making scientific and administrative decisions including the allocation of funds for intervention
studies; Aim 3. Develop a review panel that will identify, review and monitor clinical trials and behavioral
interventions in a manner consistent with progression through the NIH Stage Model and overall Center goals;
Aim 4. Monitor all clinical trials and describe their results in standardized annual progress reports to NIA; Aim
5. Work with NIA and the Roybal Coordinating Center to develop metrics that can be used to evaluate clinical
trials and code key characteristics that can be used to compare them. Aim 6. Coordinate travel to national
Roybal Center meetings annually at meeting sites designated by NIA and share key findings with other funded
Centers; Aim 7. Encourage/Facilitate the development of networks among researchers, commercial
interests, community interests, program design interests, and governmental entities to support translation
activities that will expand the reach of our Center’s activities.
The achievement of these aims and the conduct of rigorous research in the thematic areas of focus
identified are expected to contribute substantially to reduced risk for AD and improved cognitive and
physical functioning of older adults in Chicago, the Midwest, nationally and, potentially, internationally.

Public health relevance
Administrative Core Narrative Our proposed UIC Midwest Roybal Center for Health Promotion and Translation seeks to turn the findings of behavioral research interventions into real-world ways of improving the physical and brain health and quality of life of older adults at risk of Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD). The Administrative Core will play a vital role in ensuring that our renewal Center achieves its mission by enrolling key members of the policy, academic, and practice communities into our External Advisory Committee and by engaging outstanding UIC faculty as members of our Executive Committee.